Scientific and Technical Core

SCIENTIFIC AND TECHNICAL CORE PROJECT SUMMARY
The Scientific and Technical Core (ST) will invest in data and statistical expertise and computing infrastructure
to stimulate, advance, and support innovative, high-impact, interdisciplinary research on key questions in
population dynamics. The ST Core will enhance the research productivity and capabilities for CCPR affiliates,
and it will also provide enhanced support for junior population researchers who receive priority for services.
The ST Core has the following four specific aims: 1) Provide expertise and training in the choice, development,
and implementation of computational and statistical methods; 2) Expand research and data infrastructure in
large data storage and computation for population research; 3) Offer research-centered workshops and
institutes that feature state-of-the-art statistical and computational methodology for advancing population
research; and 4) Facilitate dissemination of data and research findings to external audiences.
Demand for data and computing services at CCPR has increased rapidly in the number of projects served and
projects' methodological and data and computing demands. The ST Core will seamlessly integrate across the
Cores, keeping population research in the foreground while investing in technical expertise and infrastructure
to research critical questions population dynamics. The Core also provides activities and services to scientists
at under-resourced institutions.